Implementing mental health interventions for pregnant adolescents in primary care LMIC contexts

SUMMARY
High prevalence of adolescent pregnancies in low-and-middle-income countries (LMICs) has resulted in a tremendous
public health burden. Many adolescent pregnancies are unwanted, unplanned, and outside of marriage. When adolescent
girls become mothers, their opportunities for economic and educational growth are limited. A burgeoning number of
adolescent mothers from LMICs are also marginalized due to poverty or gender-based traditions, which further limit their
access to health resources, social protection/ support and personal development. Structural inequalities and adverse
circumstances have resulted in high prevalence of depression in adolescent mothers. Despite the enormous mental health
needs for adolescent mothers in LMICs, child and adolescent mental health service remains in its’ infancy. There is a need
to advance cultural and context-sensitive perinatal depression interventions that can align with adolescents’ living
contexts and developmental needs and simultaneously address multiple resource challenges in provision of mental health
care in LMIC settings. This application seeks to respond to these adolescent perinatal depression intervention and
implementation research gaps by i) utilizing WHO Mental Health Treatment Gap Action Program (mhGAP) and Group
Interpersonal psychotherapy (IPT-G) depression care packages that has shown to be efficacious for adult depression, and
further test the approaches in adolescents with perinatal depression in Kenyan maternal and child health (MCH) service
settings. Three key research questions will be studied: (i) how to improve fit of the mhGAP/IPT-G-depression intervention
model for pregnant adolescents in Kenya, (ii) how to effectively integrate task-shifting/sharing and collaborative strategies
with MCH clinical workflow to implement mhGAP/IPT-G depression intervention for pregnant adolescents in MCH
settings, and (iii) whether the adapted mhGAP/IPT-G are feasible-acceptable-effective in addressing perinatal depression
in adolescents. Considering the demand-resource gap, as MCH clinics usually serve high volume of adolescents with
perinatal depression but have limited resources, this study will also explore other cost-effective strategies, such as study
feasibility of applying long and mini version of IPT-G and other family/adolescent peer co-lead approach of intervention
implementation. This study will be carried out using a cross-disciplinary partnership approach. The specific aims of this
study are to: 1) explore barriers and strategies to improve mhGAP-IG/IPT-G fit and implementation for adolescent
perinatal depression in MCH clinics in Kenya; 2) Develop adapted version of IPT-G/ and mhGAP-IG, and build MCH
capacity for implementation; and 3) test feasibility and implementation-effectiveness outcomes for the adapted version of
mhGAP-IG/ IPT-G.

Public health relevance
PROJECT NARRATIVE Pregnant adolescents in Sub-Saharan-African (SSA) are burdened by significant unmet health needs including lack of access to mental health services. This study seeks to enrich WHO’s mental health depression intervention with culturally and developmentally sensitive implementation strategies in primary care settings. This study aligns closely with the NIMH strategic plan, Kenya Vision 2030, UN SDGs, and WHO mhGAP framework, and its results will advance implementation research and yield need knowledge and tools for addressing similar global health gaps in other LMICs.